CORE B-Data Management, Harmonization, and Information Transfer Core

Core B Project Summary
Core B (Data Management, Harmonization, and Information Transfer Core) is responsible for
facilitating analysis of Alzheimer’s Disease Sequence Project (ADSP) data and other relevant
projects by processing and harmonizing all relevant genetic and functional genomics (FG) data.
Core B will manage all phenotype, genotype, annotation, and analysis results, and distribute
data/files to all ADSP investigators and to NIA Genetics of Alzheimer’s Data Storage Site
(NIAGADS), the NIA-designated qualified access repository for AD genetics research. Specific
Aims are: (1) Receive and manage all relevant genotypic, phenotypic, and functional genomic
data; (2) Calling SNVs, indels and structural variants (SVs) from sequencing data; (3) Develop a
GCAD haplotype reference panel with GCAD WGS data for GWAS imputation; (4) Facilitate
harmonization of FG/omics data by developing best practices for data processing and
coordinate harmonization of ADSP FG Program and other relevant omics data; (5) Support
GCAD information technology needs and information dissemination activities.